11th Symposium on Hemostasis at University of North Carolina at Chapel Hill

Summary
Funding is requested for the registration fees and travel costs of invited speakers and discussion leaders as well
as registration fee support for graduate students, postdocs, and early/mid- career scientists with an emphasis
on women and underrepresented minorities to attend the 2024 11th Symposium on Hemostasis at the University
of North Carolina (UNC) at Chapel Hill. The theme of the 2024 Symposium will be coagulation and platelet
biology at the intersection of health and disease. The program is designed to bring together experts to present
their most recent cutting-edge findings centered on defining novel mechanisms and innovative therapeutic
advances in hemostasis and thrombosis. Indeed, recent data suggest that coagulation proteins and platelets are
tied to numerous pathological processes through mechanisms both dependent and independent of their
traditional roles in hemostasis and thrombosis. Our invited speakers will present their latest and emerging work
across a spectrum of basic science and clinical topics where coagulation proteins and platelets play a functional
role, including cardiovascular disease, aging, cancer, infection and immunity, as well as tissue remodeling and
regeneration. Priority will be placed on highlighting both the role these proteins play as disease modifiers, as
well as the utility of employing or targeting these factors for diagnosis and therapy. Indeed, a major goal for the
2024 Symposium on Hemostasis is highlighting the translation of basic research findings into the clinical practice.
In addition to invited speakers and discussion leaders, attendees will be selected by invitation and from
applications submitted online. They will be chosen to represent a diverse spectrum of research, with a strong
emphasis on equity of opportunity and inclusion of individuals across all demographic metrics. Additional efforts
will be committed to recruit women and trainees of underrepresented groups as speakers in the ‘Hot Topics’
session and as poster presenters. An intended strength of this meeting will be the interaction and networking of
young scientists in the field with the discussion leaders and the speakers. Collectively, the specific aims for the
2024 11th Symposium on Hemostasis are to: (i) provide an environment that facilitates lively and open
discussions between early career, mid-career, and established scientists that fuels the process of scientific
discovery in the hemostasis and thrombosis community; (ii) provide a platform of support for the careers of junior
scientists, including predoctoral and postdoctoral trainees, to ensure growth of the field; (iii) promote collaborative
and interdisciplinary scientific research that opens channels of long-term interaction and networking that
enhances diversity in the field; and (iv) raise the professional development of under-represented groups in the
hemostasis and thrombosis community. Through these specific aims the 11th Symposium on Hemostasis will
reveal the next chapter of discovery and innovation for hemostasis and thrombosis research while helping to
establish and build on the collaborative relationships necessary to push the field forward.

Public health relevance
Narrative Basic science and clinical research into blood coagulation proteins and platelets is critical as bleeding and thrombotic disease remain the leading causes of death worldwide. Moreover, recent advances have identified important roles for clotting proteins and platelets in many pathological processes beyond bleeding and cardiovascular disorders, including cancer, aging, and infectious diseases. The 11th Symposium on Hemostasis provides an ideal setting and opportunity for scientists and clinicians to share their latest advances, as well as to welcome trainees into this exciting field of study.